Improving Access to Curative Therapies for Hepatocellular Carcinoma

ABSTRACT
Lauren D. Nephew MD, MA, MSCE’s long-term career goal is to become an independent, externally funded researcher and leader in developing multilevel interventions to reduce disparities in access to treatments for liver disease and gastrointestinal malignancies. She has identified improving access to curative therapies for hepatocellular carcinoma (HCC) as a critical issue to address to achieve this goal. This proposal describes a 4-year comprehensive program of training and mentored research for an academic career in health services research with a special focus on improving health care access and outcomes for populations experiencing adverse social determinants of health (SDOH). This is in line with NIMHD’s commitment to combating health disparities. While Dr. Nephew has a strong background in epidemiology, this K23 will provide key training in using human-centered design research methods for intervention development, randomized controlled behavioral trials, and implementation of interventions within health systems. Patients with chronic liver disease who experience adverse social determinants of health are approximately 50% less likely than their counterparts to receive curative therapies for hepatocellular carcinoma (HCC) even when presenting with early-stage disease. Reasons for disparities in mortality are in part related to failure to progress through the complex HCC care continuum to access curative therapies as a result of the distribution the SDOH. The HCC-EduLink intervention we propose to develop is designed to: a) improve patients’ HCC-related knowledge; b) screen patients for social needs and substance use and refer to social work for linkage to local services; and c) use our multidisciplinary HCC tumor board to facilitate linkage to subspecialty HCC cancer care. The objectives of this application are to develop the education program component of the HCC-EduLink intervention and pilot test the full multi-level intervention designed to address patient- and system-level SDOH variables and facilitate access to HCC curative therapies in a cohort of patients with HCC. Dr. Nephew’s multidisciplinary mentorship team, including a world-renowned gastroenterologist, an expert in interventions to reduce cancer disparities, and a behavioral health statistician, will provide expert guidance to complement her coursework and experiential learning. The environment including the Indiana University Simon Cancer Center, Clinical and Translational Science Institute, the Eskenazi Safety-net Hospital and the Indiana University Academic Health Center, make this an ideal environment for her training and to complete the proposed aims. Upon completion of the proposed research and training, Dr. Nephew will submit a competitive R-level grant to test the pilot intervention in a larger randomized trial and will possess the skills and experience needed to make a sustained and impactful contribution to reduce HCC mortality through evidenced-based interventions in other populations.

Public health relevance
Public Health Relevance Patients with chronic liver disease who experience adverse social determinants of health (SDOH) are less likely than others to receive curative therapies for hepatocellular carcinoma (HCC) even when presenting with early-stage disease. Reasons for disparities in mortality are multifactorial but may be related to failure to progress through the complex HCC care continuum to access curative therapies. The HCC-EduLink intervention we propose to develop is designed to: a) improve patients’ HCC-related disease and treatment knowledge; b) screen patients for social needs and substance use and refer to social work for linkage to local services; and c) use our multidisciplinary HCC tumor board to facilitate linkage to subspecialty HCC cancer care, improving access to curative therapies for patients with chronic liver disease and adverse SDOH.